MRI Technology for Greater Efficiency and Improved Value

PROJECT SUMMARY:
The overall goal of this application is to design technologies that improve the value of MRI, and
specifically mitigate many of the complications the negatively impact this value. The scope of MRI
value is vast, but can be expressed by efficiency (high patient throughput and consistent image
quality), accessibility (better scope of use and equity of availability), safety, and user experience
for the patient, technologist, and interpreting physician. The wide reach of this goal reflects a
strategy to improve these expressions of value broadly, if not completely. The motive for a
broad strategy grows from observations that shared complications such as scanning
inefficiencies, patient anxiety, inconsistent image quality, and technologist distraction from the
patient reduce many of these value expressions, which in turn results in a cascade of negative
impacts on each other. Thus, our two-fold aim is to improve efficiencies directly with
optimized scanning, and also to mitigate complications that impede value at several levels.
This application creates and brings together a broad array of technologies and work to achieve
these aims with design goals of (1) scanning efficiency, (2), operational simplicity, (3)
operational clarity, and (4) a strong patient focus. Specific outcomes from this application will
include (i) faster scanning for most common clinical sequences, (ii) consistently higher image
quality and consistent signal contrast, (iii) fewer operational and protocoling errors, (iv) faster
scanner operation (time between scans), (v) scans which are quieter and have less rf power
deposition (for patients with active implants), and (vi) less distraction of the technologist from an
ideally patient-centered role. This drive towards simplicity and consistency, along with improved
experience of the technologist and interpreting physician, should improve access, and is
urgently needed given the dire shortages of both technologists and radiologists along
with expected increases in the need for diagnostic imaging given population trends. Specific
technologies introduced include (1) a portfolio of spiral-based, SNR-optimal sequences
designed to be well-matched with modern, AI based reconstruction, (2) supporting infrastructure
to automate and clarify a wide array of operational tasks in order to remove technologist
distraction, prevent errors, and improve consistency, and (3) introduction of a highly novel
approach to protocoling and operating the scanner that is designed for the user and employs a
physics-free lexicon. We will test the performance of these technologies for their speed, image
quality, and clarity, and deploy them in a clinical venue for evaluation.

Public health relevance
PROJECT NARRATIVE: This application will create a group of technologies that work together to make magnetic resonance imaging (MRI) more efficient, with much shorter exams, better image quality, wider and more equitable accessibility to the public, safer, and less stressful. It will do this by focusing on improving efficiency in tandem with removing many of the barriers of cost, availability, complexity, and aggravations that limit use today. By solving these challenges holistically, it will improve the value of nearly all areas of clinical MRI.